Clinical and Translational Research Infrastructure Network IDeA-CTR

MW CTR-IN Program -- Abstract
The diverse Mountain West (MW) population continues to be plagued by high rates
of health disparities (HD) and lower life expectancy rates when compared to the rest of
the US1. The MW Clinical and Translational Research Infrastructure Network (CTR-IN)
was established in 2013. During the last 4 years, we have created an impactful and
transformative research network with our 13 MW university partners located
geographically among 7 Institutional Development Award (IDeA) states to address the
health disparities affecting the MW population in Year 6-10. Yet, despite this huge territory
and an overall insufficient regional clinical research infrastructure, we have successfully
created and implemented a highly functional CTR-IN program in the last 4 years that has
seeded a transformative culture of CTR among the 13 MW universities. Over the last 4
years, we created and implemented 4 highly productive Cores consisting of Pilot Grants,
Biostatistics, Professional Development and Administration that have positioned us to
focus on addressing the health disparities in our MW region for the next 5 years.
Hence, we propose to expand the original mission of the MW CTR-IN Program by
further enhancing the research infrastructure in the 7 MW IDeA states for the conduct of
rigorous clinical and translational research (CTR) focused on health disparities.
The 3 major themes of our proposal are as follows: (1) CTR focused on the MW health
disparities; (2) Priority on the professional development of the MW junior faculty
investigators; and (3) Providing leadership to the other IDeA programs & Universities in
the MW region. Hence, we are proposing 4 major aims to focus our activities on the health
disparities in the MW region through rigorous CTR as follows:
Aim 1. Enhance the infrastructure and human resources required to conduct rigorous
CTR in our 7 IDeA MW states at our 13 major public university partners.
Aim 2. Focus on the health disparities experienced by our diverse populations such as
the medically underserved and/or rural communities in our 7 IDeA MW states through
our CTR programs.
Aim 3. Enhance the ability of our IDeA universities and investigators to develop
competitive clinical and translational research grants for subsequent extramural funding.
Aim 4. Foster increased collaboration and coordination of clinical and translational
activities within and across our 7 MW IDeA states and our 13 MW university partners.

Public health relevance
Overall -- Project Narrative In our 7 Mountain West (MW) IDeA states, health disparities are a major health crisis. During the past four years, the MW CTR-IN program has established a research infrastructure working in conjunction with our 13 MW University partners located geographically among our 7 IDeA states. The MW CTR-IN program plans to expand the original mission of the CTR-IN program by further enhancing the research infrastructure of the MW region for the conduct of rigorous clinical and translational research to focus on health disparities in years 6-10.